Determining the Pathogenic Roles of Granzyme K+ CD8 T Cells Unexpectedly Expanded in Rheumatoid Arthritis Synovium and Other Diseased Tissues

Project Summary/Abstract
This proposal is a five-year research plan with an overarching goal of determining the dominant effector
functions of granzyme K-expressing CD8 T cells in synovial tissue in rheumatoid arthritis. Inflamed synovial
tissue from patients with rheumatoid arthritis contains a large number of CD8 T cells, in some cases
representing up to 30% of live cells. We have found that these cells do not express high levels of genes and
proteins typically expressed by cytotoxic T lymphocytes, such as GZMB (granzyme B), PRF1 (perforin), and
GNLY (granulysin). Instead, these CD8 cells express large amounts of granzyme K, a protease with a
cleavage specificity very different from granzyme B. Similar granzyme K-expressing cells have also been
detected in tissues in several other autoimmune diseases as well as in many different cancers. Given the
abundance of this cell type at the sites of disease in so many different human conditions, determining the effect
of granzyme K-expressing CD8 T cells on surrounding cells is vital for understanding their role in disease
pathogenesis and for determining how best to target these cells with new treatments.
The specific aims proposed here will investigate the effector mechanisms of granzyme K-expressing CD8 T
cells using a strategic combination of in vivo, in vitro, and in situ approaches. Aim 1 uses an antigen-induced
mouse model of inflammatory arthritis to determine whether granzyme K-expressing cells in inflamed joints are
antigen-specific and -activated or whether they are antigen-independent bystander cells, i.e., recruited and
activated by the general inflammatory milieu of the synovium. Aim 2 systemically dissects the relative potency
of known effector functions of granzyme K-expressing CD8 T cells on the recruitment, activation, and
differentiation of myeloid cells, one of the most pro-inflammatory cell types in rheumatoid arthritis synovium
and other inflamed tissues. Aim 3 uses multiplex imaging and spatial transcriptomics to identify and compare
molecular footprints of granzyme K+ CD8 T cell-associated effector functions in human rheumatoid arthritis
synovial tissue samples.
This study integrates mouse models, mechanistic cellular immunology studies, and cutting-edge spatial
technologies to a newly identified CD8 T cell subset that is highly enriched in rheumatoid arthritis synovium
and many other human diseases. This work builds on a long-standing collaboration of the PI, a rheumatologist
and translational cellular human and mouse immunologist, and co-I Dr. Fan Zhang, a computational biologist
with expertise in synovial tissue -omics analysis and spatial transcriptomic methods development. The findings
of this study will inform the design of new therapeutics for rheumatoid arthritis and other autoimmune diseases.

Public health relevance
Project Narrative This project will determine the dominant functional effects of granzyme K-expressing CD8 T cells in synovial tissues in rheumatoid arthritis. Granzyme K-expressing CD8 T cells are abundant in tissues in many autoimmune diseases, including lupus nephritis and inflammatory bowel disease, and they have also been detected in many cancers and several infectious diseases. Our findings have the potential to identify new pathogenic pathways and treatment targets in human autoimmune diseases as well as malignancies and infections.